2023 Mammary Gland Biology Gordon Research Conference and Gordon Research Seminar

Project SUMMARY
The Gordon Research Conference on Mammary Gland Biology (GRC MGB) and the highly successful Gordon
Research Seminar (GRS) that accompanies this meeting are unique amongst basic biology and breast cancer
conferences as they bring together a diverse mix of scientists and clinician-scientists interested in the molecular
and cellular mechanisms that govern normal mammary gland development, lactation physiology, tumor initiation,
and progression and metastasis. There is a strong focus on basic mechanisms of normal and breast cancer
biology and treatment (based on elucidating the early and later events that contribute to breast cancer onset and
progression) and emerging `cutting edge' science relevant to the field. The GRC MGB/GRS is the only
conference focused on harnessing insights from normal mammary gland biology and physiology to understand
events that give rise to breast cancer and has become a `must attend' for mammary gland biologists and cancer
researchers (particularly in basic and translational research areas) the world over. The Specific Aims of the 2023
GRC/GRS are to deliver a program that addresses critical scientific questions and controversies in the field. The
2023 conference will focus on recent discoveries and outstanding questions in the mammary gland biology field
that have immediate and long-term relevance to breast cancer prevention and treatment as well as human
lactation and infant health. International experts have been confirmed to address the topics of (1) Phenotypic
and genetic approaches for personalization of treatment. (2) Mapping normal and diseased states. (3) Nutrients
and metabolism regulation of normal and cancer. (4) Hormones and systemic regulation of normal biology and
cancer. (5) Microbiome and inflammation in normal biology and disease. (6) Microenvironment modulation of
development, function, and cancer. (7) Immune modulation in normal biology and cancer. (8) Epigenetics and
plasticity during normal biology and cancer. (9) Lifestyle and genetic factors and breast cancer etiology.

Public health relevance
NARRATIVE Although there has been considerable progress in improving breast cancer and lactation outcomes, the statistics underscore an unmet need for new treatments, prevention strategies, and a parallel understanding of mechanistic biology. Gaining new insights into the normal biology of the mammary gland, physiological processes such as lactation, and the perturbations that give rise to breast cancer are arguably the most critical steps toward improving human health outcomes tied to this one organ. In its 50th year, this conference aims to disseminate the latest unpublished data and stimulate discussion among leading investigators and trainees on the most recent findings and future research regarding the cellular and molecular mechanisms of mammary gland development, nutrient sensing, immunity and inflammation, and progression to metastasis.